SUBCUTANEOUS UT 15 IN PATIENTS W/ PRIMARY PULMONARY HYPERTENSION PRE

This study will compare the efficacy of UT-15 given subcutaneously vs. conventional therapy alone in treating patients with primary pulmonary hypertension.